Center for Public Genomics 2.0

DESCRIPTION (provided by applicant): Duke University's Center for Public Genomics (CpG) was established in 2004 to study two important aspects of genomics research: intellectual property (IP), and norms and practices of sharing data and materials. The Center embraces legal scholarship, economic and business theory, empirical social science, history, philosophy, and literary studies. Specific projects analyze the role of various kinds of IP and the ways that legal rules and practices in business and in science affect genomics and its applications. One theme is the value of a scientific commons ~ information and technologies that are placed in public databases, published in the open literature, or widely shared at low cost. CpG research is intended to inform policies to promote wide use of valuable information while preserving incentives to create information and invent new technologies. CpG 2.0 will extend the first five years of research. It will turn to how IP law treats genomic information, how IP can promote or impede genomics, and how existing patents might affect science and genetic diagnostics in an era of ubiquitous full-sequence genomic analysis. CpG 2.0 will also study how IP is cropping up in surprising places. It will probe more deeply into how and why patents were important in the story of BiDil, the first drug that FDA approved for use in a racial subpopulation. Genomics has also sometimes flared into controversy when it involves US tribes, Canadian First Nations, and populations in Africa. CpG will collaborate with others addressing these issues, studying how IP can provoke conflict but may also be a tool for sharing benefits. CpG aspires not only to do the highest quality research, but also to make its research available to those making policy decisions in useful form. CpG 2.0 includes two cores based in Washington, DC: a Genomic Policy Resource that includes the DNA Patent Database (Georgetown University) and a policy engagement core at the Genetics and Public Policy Center (Johns Hopkins University).

Public health relevance
RELEVANCE: This grant investigates how intellectual property rights affect scientific research, sharing of information and materials, and development of genomic products. Research results will help policymakers alter laws to promote science and innovation, and help scientists create sharing practices that will improve their access to the resources they need. The results will help public health because advances in genomic sciences can be made more rapidly and with reduced costs.